VALIDATION OF MR TECH OF THERAPEUTIC EFFICACY FOR DRUG DISCOV IN ALZH DISEASE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Alzheimer's work has focused on two major areas: evaluation of pulse sequences for best detection of amyloid plaques and evaluation of different MR techniques to detect neurodegeneration in genetically modified mice.